Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core
The overall goal of the Administrative Core is to provide leadership, coordination and oversight for
PREMIER, the Precision Medicine in Rheumatology Center (P30) at UCSF. Under the direction of Drs. Mary
Nakamura (PD) and Jinoos Yazdany (Associate PD), the Administrative Core serves as an entry portal for
researchers interested in pursuing advanced precision medicine studies in rheumatic diseases. The
Administrative Core will work directly with investigators to link them with PREMIER Core services and facilitate
new collaborations between clinicians seeing rheumatic disease patients, basic researchers developing cutting-
edge technologies, and bioinformatics experts capable of integrating complex streams of data for analysis. The
Administrative Core will assess needs for project planning and biospecimens and arrange appropriate
consultation with PREMIER Cores 1) Clinical and Data Informatics (CDI) Core, 2) Genomic Technology (GT)
Core, and 3) Integrative Bioinformatics (IB) Core.
The Administrative Core provides administrative and financial oversight for all the PREMIER Cores and
ensures the smooth operation of the Center. The Administrative Core coordinates membership, communications
and an enrichment program involving seminars, training workshops, a mentoring program, a Pilot Grant and a
Core Usage Grant program. PREMIER makes patient cohorts and biospecimens, advanced genomic
technologies and complex informatics services accessible through our Resource Cores, along with services to
assist with complex experimental planning. In this way we bring together collaborative groups that can advance
innovative studies in rheumatic diseases. Through training, mentoring and funding opportunities we further
support and encourage young investigators to focus their precision medicine research on rheumatic diseases.
The Administrative Core creates an infrastructure that supports both PREMIER Investigators and the
Resource Cores. The overall goal of PREMIER is to foster innovative research and collaborative studies that
will lead to better delineation and targeted treatment of complex rheumatic disease.